Administrative Core

ADMINISTRATIVE CORE (CORE A)
PROJECT SUMMARY
The Administrative Core (Core A) provides overall leadership and management of the DC CFAR in support of
its mission to end the HIV epidemic and improve the health and quality of life of persons with HIV in
Washington, DC and beyond in partnership with community and government. The Administrative Core is led by
DC CFAR Director Dr. Alan E. Greenberg, Co-Directors Dr. Manya Magnus and Dr. Amanda Castel, and
Administrative Director Ms. Brandi Robinson. The Core staff includes a Center Associate who provides overall
technical and communications support; a Core Manager who supports the Developmental Core and three
Scientific Cores; a Community Coordinator who serves as a liaison between DC CFAR investigators and the
DC HIV community; and a fiscal management team that oversees the DC CFAR budget and multiple
subcontracts.
The Administrative Core promotes and supports collaborative HIV science for 260 investigator members at
nine partner institutions by addressing four Specific Aims. First, the Core provides leadership and governance
through its support and coordination of the DC CFAR Executive Committee, three Advisory Committees, five
Cores, two Scientific Working Groups (SWGs) and two Scientific Interest Groups (SIGs) which function as
developmental SWGs. Second, the Core promotes multi-institutional HIV science through supporting NIH grant
proposals, pilot award programs, service provision, and seminars. Third, the Core manages the DC CFAR
budget and tracks and evaluates core service provision, grant and publication productivity, and regulatory
documentation. Fourth, the Core ensures effective communication and collaboration among DC CFAR
investigators and their community, government and CFAR network partners.